ADPKD: Understanding mechanisms, Discovering treatments.

DESCRIPTION (provided by applicant): The objective of this proposal is to continue our studies on understanding the mechanisms of tumor necrosis factor-alpha (TNF?α) signaling in cystogenesis. TNF?α through its receptor and through the ability of the receptor associated proteins to form the membrane bound pro-survival complex I as well as the cytoplasmic pro-death complex II help cancer cells to escape apoptosis. The inhibitor of apoptosis (IAP) antagonist, Smac-mimetic, is able to target the above TNF?α-mediated complexes to induce cancer cell death. Our studies have suggested that TNF?α can promote ADPKD progression and our preliminary studies have further found: 1) TNF?α is always present in cyst fluid from ADPKD kidneys; 2) Loss of polycystin function leads to increased expression of TNF?α receptor I (TNFR-I); 3) The components of proteins in complex I and complex II are upregulated in Pkd1 mutant MEK cells; 4) Most importantly, TNF?α alone could not induce normal or Pkd1 mutant epithelial cell death even at high concentrations, while, TNF?α together with transiently transfected Smac could induce only Pkd1 mutant cystic epithelial cell death but had no effect on Pkd1 wild type kidney epithelial cells. Furthermore, the following evidence supports the connection between TNF?α and Id2 signaling pathways: 1) TNF?α activates mTOR through IKKβ and mTOR regulates the functional differentiation of mammary epithelial cells through regulating the expression of Id2; 2) Receptor activator of NF-κB ligand (RANKL), a TNF family molecule, regulates mammary epithelial cell proliferation via Id2 by triggering marked nuclear translocation of Id2. Based on these findings, we hypothesize that: TNF?α and its receptor are able to regulate cystic epithelial cell apoptosis through the membrane bound pro-survival complex I and cytoplasmic pro-death complex II and further regulate cystic epithelial cell proliferation and differentiation through mTOR or RANKL-mediated Id2 signaling. To test our hypothesis, we propose three aims: 1) To Investigate the mechanism(s) of TNF?α signaling in regulation of kidney epithelial cell survival; 2) To determine the potential role and mechanism of the IAP antagonist, Smac-mimetic, in regulating TNF?α-dependent cystic kidney epithelial cell death; 3) To investigate whether TNF?α signaling regulates cystic epithelial cell proliferation and differentiation through mTOR and RANKL mediated Id2 signaling. Accomplishing this project will further elucidate the role of the pathways downstream of the polycystins in cystogenesis and will identify key regulatory components that may serve as effective targets to slow disease progression.

Public health relevance
PUBLIC HEALTH RELEVANCE: The objective of this proposal is to continue our studies on understanding the mechanisms of tumor necrosis factor-alpha (TNF?α) signaling in cystogenesis. Our general hypothesis is that TNF?α through its receptor to form a membrane bound pro-survival complex protects the cystic epithelial cell apoptosis and IAP antagonist, Smac-mimetic, can induce TNF?α dependent cystic epithelial cell death to further prevent cyst expansion/formation. Accomplishing this project will further elucidate the role of the pathways downstream of the polycystins in cystogenesis and will identify key regulatory components that may serve as effective targets to slow disease progression. The information from our studies will be likely to open new avenues in the research of ADPKD and establish the foundation for developing effective therapies of the disease. Project Narrative The objective of this proposal is to continue our studies on understanding the mechanisms of tumor necrosis factor-alpha (TNF-a) signaling in cystogenesis. Our general hypothesis is that TNF-a through its receptor to form a membrane bound pro-survival complex protects the cystic epithelial cell apoptosis and IAP antagonist, Smac-mimetic, can induce TNF-a dependent cystic epithelial cell death to further prevent cyst expansion/formation. Accomplishing this project will further elucidate the role of the pathways downstream of the polycystins in cystogenesis and will identify key regulatory components that may serve as effective targets to slow disease progression. The information from our studies will be likely to open new avenues in the research of ADPKD and establish the foundation for developing effective therapies of the disease. PHS 398/2590 (Rev. 11/07) Page___ __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Tumor necrosis factor-alpha (TNF-a) via its receptor and the receptor associated proteins to form the membrane bound pro-survival complex I as well as cytoplasmic pro-death complex II which enable cancer cells to escape apoptosis. The inhibitor of apoptosis (IAP) antagonist, Smac-mimetic, is able to target the above TNF-a-mediated complexes to induce cancer cell death. Our studies suggest that TNF-a can promote ADPKD progression and our preliminary studies have further found that: 1) TNF-a is always present in cyst fluid from ADPKD kidneys; 2) Loss of polycystin function leads to increased expression of TNF-a receptor I (TNFR-I); 3) The components of proteins in complex I and complex II are upregulated in Pkd1 mutant MEK cells; 4) Most importantly, we found that TNF-a alone could not induce normal or Pkd1 mutant epithelial cell death even at high concentration, however, TNF-a together with transiently transfected Smac could induce only Pkd1 mutant cystic epithelial cell death but had no effect on Pkd1 wild type kidney epithelial cells. Based on these findings, we hypothesize that: HYPOTHESIS: TNF-a and its receptor are able to regulate cystic epithelial cell apoptosis through the membrane bound pro-survival complex I and cytoplasmic pro-death complex II and further regulate cystic epithelial cell proliferation and differentiation through mTOR or RANKL-mediated Id2 signaling. To test our hypothesis, we propose three aims: Specific Aim 1: To Investigate the mechanism(s) of TNF-a signaling in regulation of kidney epithelial cell survival. In Aim 1a, we will investigate the potential mechanism (s) underlying the elevated levels of TNF-a in cyst fluid and determine whether TNF-a is able to autoregulate its own biosynthesis in cystic epithelial cells. In Aim 1b, Aim 1c and Aim 1d, we will examine the potential mechanism of TNF-a signaling in the regulation of kidney epithelial cell survival. Specific Aim 2: To determine the potential role and mechanism of the IAP antagonist, Smac-mimetic, in regulating TNF-a-dependent cystic kidney epithelial cell death. In Aim 2a, we will investigate whether Smac-mimetic is able to induce Pkd1 mutant MEK cell death. In Aim 2b, Aim 2c and Aim 2d, we will investigate the potential mechanism of Smac-mimetic induced cystic epithelial cell death in vitro. In Aim 2e, we will test whether Smac-mimetic is able to prevent cyst formation in vivo in Pkd1 conditional knockout mice. Specific Aim 3: To investigate whether TNF-a signaling regulates cystic epithelial cell proliferation and differentiation through mTOR and RANKL mediated Id2 signaling. In Aim 3a, we will investigate the expression and localization of Id2 in response to TNF-a stimulation in cultured kidney epithelial cells. In Aim 3b, we will investigate whether TNF-a signaling regulates Id2 function through the mTOR pathway in kidney epithelial cells. In Aim 3c, we will investigate whether the RANKL pathway regulates Id2 nuclear transportation in kidney epithelial cells. Significance: This study will answer a key question of how cystic epithelial cells escape apoptosis during development. Accomplishing this project will elucidate the role of the pathways downstream of the polycystins in cystogenesis and will identify key regulatory components that may serve as effective targets to slow disease progression. The results from this study will further the field of PKD biology. Moreover, the presence of TNF-a in cyst fluids will necessitate the sole application of Smac-mimetic to treat ADPKD patients and will then be simple and efficient. Completion of these studies will form the basis for translation into clinical trials of therapeutics for ADPKD.